Production of Aza-TdC Capsules for Clinical Use

PRODUCTION OF TWO THOUSAND CAPSULES OF 8 MG AZA-TDC. The batch of product was produced by the contractor and sent to clinical repository. The shelf-life was also evaluated. The drug product will be used in the NCI clinical trials.